Training Modules at Wayne State University to Promote Safe and Inclusive Environments

Abstract Wayne State University (WSU) is a pre-eminent, public, urban research university with a demonstrated commitment to excellence grounded in its active engagement in initiatives that have enhanced diversity, achieved increased equity, and started to build a culture of inclusion for its students and community. The National Institutes of Health recognize this commitment through the support of institution-wide initiatives such as the Wayne State Initiative for Maximizing Student Development (IMSD), now in its 43rd year, and more recently, ReBUILDetroit, a collaboration for Building Infrastructure Leading to Diversity (BUILD) in the biomedical sciences in the Detroit Metropolitan Area. Despite excellent infrastructure, resources, and our decades old demonstrated and active commitment to diversity, equity, and inclusion (DEI), these frameworks have not been as successful in supporting the graduate student experience, limiting the university's ability to reach its full potential in research and scholarship in the biomedical sciences. Located in the heart of one of the most diverse cities in the USA, Detroit, Michigan, WSU is uniquely positioned and committed to the restorative and sustainable reconstruction of its structures and a shift in its culture to recruit, retain, and support the success of graduate students from marginalized groups who are committed to DEI. In alignment with the overall mission of WSU, the university is currently creating and implementing a model for inclusive excellence that will be piloted in the biomedical sciences. The leaders of this initiative, the Deans of the Schools of Medicine and Graduate School along with the Vice President for Research, as well as the broader university community are committed to a restorative approach to the achievement of equity and the creation of an environment in which the talent of all individuals with the ability and desire to achieve can reach its full potential. The integration of restorative practices and equity-mindedness into inclusive excellence was developed by this team to best serve the unique needs of WSU. Restorative practices are grounded in restorative justice and help to reduce bullying, improve human behavior, strengthen civil society, provide effective leadership, restore relationships, and repair harm. In many of our nation's institutions, this approach which can transform the experience of all constituencies and create sustained structures, policies, and procedures that are foundational for inclusive excellence, must be grounded in the restoration of the institutions and their people to a sense of belonging, hence restorative inclusive excellence (RIE). This supplement will be utilized to develop the curriculum needed for institutional transformation to support RIE, specifically in graduate education, through a series of online training modules and workshops.

Public health relevance
The Wayne State University (WSU) IMSD T32 program seeks to develop an ecosystem for graduate training that embraces equity mindedness and restorative inclusive excellence (RIE) through the establishment and implementation of four training modules. This supplement will be utilized to develop the curriculum needed for this broader institutional transformation, which will expand our current IMSD activities to the entire biochemical community that plays a role in graduate education.